Dysregulation of epidermal innate immune signaling as driver of Psoriatic-like arthritis

PROJECT ABSTRACT
Psoriasis affects 3% of the US population and a third of patients develop Psoriatic Arthritis (PsA), usually
with a delay of 5-7 years. Delayed therapy leads to poorer PsA control, yet diagnosing PsA early remains
challenging. Among the most effective therapies for Psoriasis and PsA are those that target IL23, IL17, and
TNF; yet, these therapeutics incompletely control arthritis, indicating the existence of other arthritogenic
immune pathways. We hypothesize that cutaneous inflammatory processes play a key role in triggering
psoriatic joint inflammation, which evolves following cutaneous priming to include additional immune drivers.
Addressing these hypotheses may reveal early biomarkers and novel therapeutic targets for PsA.
To investigate how skin inflammation drives PsA, we developed a novel mouse model of immune
dysregulation initiated within the epidermis. This model, termed A20eKO, uses temporal and keratinocyte-
specific loss of the gene A20 (Tnfaip3), polymorphisms of which reduce its expression and are strongly linked
to both Psoriasis and PsA in humans. A20 is a key negative regulator of innate immune signaling, and its loss
unmasks spontaneous pathogenic tissue immune processes. Remarkably, A20eKO mice not only develop
psoriasiform skin disease but also synchronous and fully penetrant PsA-like joint disease. We show that skin
and joint pathology in A20eKO mice requires IL23, IL17A, and T cells, demonstrating that epidermal signals
alone can drive arthritogenic T cells. This offers a clear model to study how psoriatic skin disease drives PsA.
In Aim 1 we focus on the pathogenic T cells triggered by keratinocyte A20 deficiency. We will use single
cell transcriptomics and paired TCR sequencing to determine the phenotype and clonal diversity of memory T
cells that expand in A20eKO skin prior to clinical onset of dactylitis. Using bioinformatic methods, we aim to
identify phenotypically similar cells in human psoriatic plaques, potentially representing skin-educated
arthritogenic T cells. In Aim 2 we dissect the pathogenic contributions of two distinct signaling pathways,
IL1/TLR and cGAS/Sting, that we discover as potently restricted by A20 in keratinocytes. Using A20eKO mice
interbred with loxP-bearing alleles of MyD88 and Sting, we will determine how unrestrained keratinocyte
signaling from these two pathways distinctly impacts psoriatic inflammation and PsA-like pathology in A20eKO
mice. In Aim 3, we dissect how the immune mechanisms driving PsA-like inflammation evolve after triggering
by cutaneous immune dysregulation. We find that delayed anti-IL23 treatment no longer prevents PsA-like
inflammation in A20eKO mice. Using Spatial Transcriptomics we will determine the immune mechanisms that
drive IL23-independent arthritis following cutaneous priming. Combining the A20eKO model with a novel method
to reversibly trigger keratinocyte innate immune signaling, we will dissect how PsA-like inflammation responds
once cutaneous immune triggers are reversed.

Public health relevance
PROJECT NARRATIVE Psoriasis affects 3% of the US population and a third of patients develop Psoriatic Arthritis (PsA), usually with a delay of 5-7 years; however, predicting which psoriasis patients will progress to PsA is challenging as is treatment of arthritis. We hypothesize that psoriatic inflammation in the skin promotes inflammation in the joints and we have developed a novel mouse model, based on known human genetic risk factors for PsA, that reflects this skin-to-joint transition in psoriatic disease. Using this mouse model, we will investigate how skin inflammation promotes joint inflammation with the goal of finding new ways to diagnose psoriatic arthritis early and identifying new treatment strategies for PsA.